Massachusetts AI and Technology Center for Connected Care in Aging and Alzheimer's Disease (MAITC)

PROJECT SUMMARY: Overall
More than 90% of older Americans would prefer to stay in their homes as long as possible as they age.
However, the prevalence of chronic illness including Alzheimer's disease (AD) and Alzheimer's disease related
dementias (ADRD) can make the goal of successful aging at home out of reach without substantial support. At-
home health care technologies hold significant promise to provide many needed forms of support, but have not
been specifically developed for older adults, AD/ADRD patients, caregivers, and their clinicians. Many existing
health monitoring technologies are burdensome to use for older adults, are not sufficiently accurate, have
specific algorithmic biases, and lack adequate usability, and the resulting deluge of data often fails to provide
information that can usefully inform caregivers and support clinical decisions. Further, many current treatment
and intervention regimes are limited in terms of their ability to be remotely delivered, managed and adapted to
patient needs and caregiver abilities over time.
The Massachusetts AI and Technology Center for Connected Care in Aging and Alzheimer's Disease
(MAITC) is a multidisciplinary Center spanning five sites – the University of Massachusetts Amherst, Brigham
and Women’s Hospital, Massachusetts General Hospital, Brandeis University and Northeastern University –
that aims to foster interdisciplinary research on the development, validation and translation of emerging AI-
enhanced technologies to enhance connections between older adults, caregivers, and clinicians in order to
more effectively support healthy aging as well as the care of patients with AD/ADRD at home. To achieve this
objective, MAITC will pursue the five aims. The first is to apply a rigorous process which involves eliciting
stakeholder needs to drive the foci of pilot studies and identifying promising technologies suitable for
incorporation into pilot research projects. The second is to form and support a multidisciplinary community of
engineers, computer scientists, behavioral scientists, medical researchers, nurses and clinicians working to
advance the goals of the MAITC. The third is to provide access to state-of-art validation facilities, diverse
cohorts across rural and urban areas, and translation and commercialization services to enable rapid, robust
and multi-faceted validation and translation of AI-enhanced technologies. The fourth is to administer a pilot
project granting process and ensure that the pilot projects are responsive to stakeholder needs, use emerging
AI and related technologies that have significant potential to improve interactions between older adults, lay
caregivers, and clinicians. The fifth is to provide training to developers, clinicians, and other stakeholders and
to disseminate findings to diverse research, development and practice communities to accelerate further
development of promising technologies and promote the adoption of validated technologies beyond the
MAITC. Through these coordinated efforts, we hope to improve the lives of older adults and their caregivers.

Public health relevance
PROJECT NARRATIVE The Massachusetts AI and Technology Center for Connected Care in Aging and Alzheimer's Disease (MAITC) seeks to develop and validate health monitoring devices and artificial intelligence technologies to support healthy aging and Alzheimer's Disease care. The MAITC will play an integral role in eliciting needs from patients, caregivers, and clinicians and supporting research projects aimed at developing new and innovative AI-enhanced technologies to address these needs.